Staphylococcus aureus Cardiac Device Infections - From the Vascular Viewpoint

PROJECT SUMMARY
For patients with advanced cardiovascular disease, implanted cardiac devices can significantly improve their
survival and quality of life. While lifesaving, cardiac devices carry the added risk of developing a cardiac device
infection (CDI), in which case the device has to be surgically removed. In many cases, patients with a CDI
present with vague symptoms and undergo a number of inconclusive tests, resulting in a delay in their diagnosis.
If left undiagnosed or untreated the mortality from a CDI is high. If identified early, CDIs can be treated swiftly,
thereby reducing infection-related complications. Currently there are no reliable methods for early prevention or
identification of CDI. Rapid and accurate CDI diagnosis is critical in cardiac device recipients who have a
Staphylococcus aureus bloodstream infection, as the risk of CDI approaches 50%. Building on the candidate's
published work, this research will use the singular resource of the Bloodstream Infection Biorepository to define
the vascular biomarker signature associated with an individual's risk for a S. aureus-CDI. Second, the biological
basis for why some, but not all patients, develop a CDI will be identified through the application of a novel in vitro
model system of bacteremia, created by the candidate in collaboration with Biomedical Engineering. This project
will: 1) define the biomarker signature associated with S. aureus-CDI, 2) determine how changes in vascular
mechanics affect infection risk, and 3) apply a novel tissue engineered blood vessel system to identify critical
endothelial-bacterial-device interactions that impact CDI risk. Results from this project will serve as a basis for
follow-up R01 proposals, which will prospectively evaluate adjunctive CDI biomarker signatures among other
etiologies of bloodstream infection and determine if a patient's endothelial phenotype is an independent risk
factor for CDI. This project has direct relevance to the NHLBI's strategic goals and objectives of identifying
phenotypic, biomarker, and molecular characteristics predictive of outcome, that when applied in clinical studies,
can predict differential response to therapy in individuals. This project will also support the candidate's transition
to an independent research career. This project will provide expertise and advanced skillsets in tissue
engineering, vascular biology, and clinical research, all of which are necessary for the candidate's long-term
career goal of identifying key factors that impact susceptibility to CDIs and developing effective therapeutic
strategies for their prevention and treatment. The primary mentor for this award is Dr. Vance Fowler, an
internationally recognized clinician-scientist in S. aureus bacteremia who has extensive experience as a mentor
of junior faculty researchers. A complementary and diverse group of mentors will provide guidance in tissue
engineering (Dr. Truskey) and vascular biology (Dr. Kontos). The candidate will use the outstanding resources
and interdisciplinary working groups at Duke University Medical Center, the Pratt School of Engineering, the
Duke Cardiovascular Research Center, and the Antibiotic Resistance Leadership Group to launch her career as
an independent physician-scientist.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is the leading cause of cardiac device infections, a devastating complication that jeopardizes the function of these lifesaving devices. This research proposal will build novel bioengineered model systems to examine how specific patient and bacterial factors interact to influence why some people with S. aureus bloodstream infection and cardiac devices (pacemakers, artificial heart valves) develop an infection of their cardiac device while others do not. The results from this research can be used to develop new diagnostics to identify patients at high risk for developing a cardiac device infection or new therapeutics to augment a person's ability to fight these infections.